NIH Diversity Program Consortium Coordination and Evaluation Center at UCLA

PROJECT SUMMARY/ABSTRACT
The overall purpose of the NIH Diversity Program Consortium (DPC) Coordination and Evaluation Center
(CEC) at UCLA is to provide the DPC's grantees with coordination and operational support, conduct data
coordination/collection and program evaluation, and disseminate best practices. In this second five-year
funding period, the DPC will be comprised of the Building Infrastructure Leading to Diversity (BUILD) awards
and newly proposed DPC Dissemination and Translation Awards (DaTA), as well as an expanded set of
National Research Mentoring Network (NRMN) programs including a NRMN Coordinating Center, a NRMN
Resource Center and up to15 NRMN U01 intervention awards.
The CEC is comprised of four cores, the Administrative Core (AC), the Data Coordination Core (DCC), the
Evaluation Core (EC) and a new Communication and Dissemination Core (CDC) in recognition of the
expanded growth of the DPC and the critical importance of both internal DPC communications and
disseminating best practices. Consistent with this second phase of the project (RFA-RM-18-005), the CEC will:
1) Provide a centralized administrative structure to support and enhance communication within the CEC,
between the CEC and the DPC, and to conduct an evaluation of CEC processes and overall performance
(Administrative Core; AC); 2) Provide state-of-the-art data collection and data management expertise, as well
as key services and training/capacity building for DPC partners for the optimal collection of DPC data to most
effectively support the overall research aims of the DPC and advance institutional sustainability (Data
Coordination Core; DCC); 3) Conduct multilevel, comprehensive assessments of the impact of the DPC using
traditional (e.g. qualitative, quantitative) and innovative (e.g. social network analysis) research methods with an
emphasis on DPC defined Hallmarks of Success at the student, faculty, and institutional levels (Evaluation
Core; EC); and 4) Develop high-impact dissemination channels for DPC best practices to peer institutions,
NIH, and other key stakeholders to create a transformative and lasting impact on the national biomedical
research training pipeline and ultimately increase diversity in the national biomedical research workforce
(Communications and Dissemination Core; DCC). As a U-award, we work in close collaboration with NIH in the
design and execution of all of our activities, in addition to being responsive to DPC awardees and facilitating
consortium leadership and activity-specific groups that help guide our activities.
In summary, the CEC will promote a collaborative environment across the DPC, provide high-quality
evaluation of BUILD and NRMN activities/interventions, and develop sustainable research tools for longer-term
dissemination of DPC findings, evaluation methods, and best practices nationally and internationally that will
remain available even after the current funding period ends.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The NIH has a program designed to test the best ways to help disabled students, students from poor families, and students and junior faculty from minority groups underrepresented in the biomedical sciences to become a scientist. The Coordination and Evaluation Center (CEC) at UCLA will evaluate the results of colleges and universities that are testing different strategies as part of this large NIH program. The CEC will determine the best strategies and then help to spread the word across the nation about the best practices that work best to increase diversity in the medical science so that other schools and organizations can benefit as well. 1